Dissecting the roles of glutamatergic receptor subtypes in spinal locomotor circuit function

PROJECT SUMMARY
Abstract
Animal survival is dependent on locomotion to successfully find shelter, locate a mate, capture prey, and avoid
predators. Although it is well established that spinal locomotor circuits in vertebrates are activated by
glutamatergic-mediated excitation, our understanding of glutamatergic signaling is incomplete. This is
important to understand since glutamatergic excitation contributes to the generation of rhythmic activity and the
amplitude of motor output. Dissecting the precise role that subtypes of ionotropic and metabotropic glutamate
receptors play in spinal locomotor circuit function will provide mechanistic data critical for understanding
locomotor circuit function. We will address this gap in knowledge by determining the roles of glutamate
receptor subtypes in the larval zebrafish spinal locomotor network using a well-validated complement of tools
that span from molecular to behavioral levels, including optogenetic activation of spinal locomotor networks,
pharmacology, electrophysiology, high-speed videography, and calcium imaging. The goal of this proposal is to
advance our mechanistic understanding of glutamatergic signaling responsible for regulating the properties of
vertebrate spinal locomotor output and spinal motor neuron recruitment. The results of these experiments will
set a foundation for investigations into the specific neuronal targets of glutamatergic actions, revealed here, in
a future R01 proposal. Since many principles of CPG function are conserved across vertebrates, we expect
these findings to translate to other animals, including humans.

Public health relevance
PROJECT NARRATIVE Animal survival is dependent on locomotion to successfully find shelter, locate a mate, capture prey, and avoid predators. The goal of this proposal is to utilize the optically transparent and genetically tractable zebrafish model system to elucidate the mechanisms of glutamatergic signaling responsible for regulating the properties of in vivo spinal locomotor output, which will set the basis for a better understanding for the control of vertebrate locomotion. Since many principles of CPG function are conserved across vertebrates it is likely that these findings will translate to other animals, including humans.